Development of multiplexed nanoscopy for ultrastructural phenotyping of retinal tissue

Project Summary
Addressing the complexities of vision at the cellular and molecular level necessitates an advanced
spatial omics technology, capable of mapping the 3D distribution of specific molecular
markers within tissue from the cellular level down to the ultrastructural scale. While spatial
proteomics technologies have revolutionized in situ molecular profiling of tissues, limitations in
resolution, epitope accessibility, sample degradation, and 3D imaging capability have hindered
their widespread impact. This is the focus of our project, which proposes to combine two
groundbreaking microscopy technologies, pan-Expansion Microscopy (pan-ExM) and FLASH-
PAINT, into a revolutionary new method named pan-OptiX. Pan-ExM enhances spatial resolution
~20x by expanding samples physically, while retaining the proteome for subsequent labeling.
FLASH-PAINT, on the other hand, allows rapid and efficient multiplexed protein labeling with
minimal sample damage. By engineering these technologies for compatibility, pan-OptiX
promises multi-scale and multi-color imaging, in 3D, across whole tissue sections, with no label
limitations due to degradation or steric hindrance. Panluminate, Inc. is a leading spatial
proteomics company which holds an exclusive license to both technologies from Yale. Our
proposed project aims to develop pan-OptiX and apply it to map the circuitry of the mammalian
retina. We specifically propose to (1) validate a second-generation pan-ExM protocol compatible
with post-expansion DNA-conjugated antibody labeling and multiplexing, (2) develop novel
FLASH-PAINT probes compatible with expansion imaging, (3) build an automated light sheet
microscope designed specifically to image pan-OptiX samples, and (4) characterize the molecular
and ultrastructural heterogeneity of the mouse retina. Ultimately, the developments proposed here
will enable Panluminate to disseminate pan-OptiX sample preparation and imaging to every
research and biopharma lab around the world.

Public health relevance
Project Narrative Understanding the intricate spatial architecture of retinal tissues and cells at size scales ranging from the cellular to the molecular level is vital for public health, offering deep insights into the cellular processes disrupted in vision and vision-related diseases. In this project, we will develop pan-OptiX, the first 3D multi-resolution and multi-color spatial proteomics technology and test it with mouse retina tissue to help elucidate the 3D cellular networks and nanoscale signatures associated with vision and vision-related disorders.